Role of C difficile Colonization in Risk of Disease

Project Summary
Clostridioides difficile is a leading cause of healthcare-associated infection with >450,000 cases yearly in the
United States. Infection prevention strategies have had limited success at curtailing C. difficile infection rates.
Making matters more difficult, individuals can also carry C. difficile asymptomatically. While carriage is both
highly prevalent and associated with increased risk of subsequent disease, only a minority of carriers actually
progress to disease. The factors responsible for preventing or promoting progression from carriage to disease
remain largely unclear. By combining recent improvements in clinical testing algorithms, statistical modeling, and
bioinformatics, we aim to undertake a more innovative and comprehensive approach to modeling C. difficile
infection. The advent of two-step testing helps to distinguish carriage from disease. Time-to-event models permit
accurate and efficient handling of longitudinal outcomes. Finally, advances in bioinformatics facilitate additional
insight into the roles of the metagenome and metabolome. Using this multi-modal approach, we seek to improve
the current understanding of progression from C. difficile carriage to disease through the following aims:
1) Identify metagenomic/metabolomic risk factors present at time of carriage that are associated with
later progression to C. difficile disease;
2) Assess for changes in the metagenome/metabolome temporally associated with progression from
carriage to C. difficile disease.
3) Identify C. difficile strain attributes (particularly those related to toxin regulation) associated with risk of
progression from carriage to disease;
An improved understanding of the factors that prevent or promote progression to disease could inform novel
targets for C. difficile prevention and better direct potential therapies to those at highest risk. My short-term goal
is to develop a skillset for the analysis of metagenomic and metabolomic data. My long-term goal is to become
adept at incorporating metagenomic and metabolomic data into prospective studies of C. difficile acquisition and
progression to disease. This proposal is designed to cultivate my development as a future leader in incorporating
metagenomic/metabolomic data into studies of infectious disease transmission and prevention.

Public health relevance
Project Narrative Clostridioides difficile infection remains one of the most common healthcare-associated infections. While C. difficile carriage is both highly prevalent and strongly associated with risk of subsequent disease, factors that prevent or promote progression to disease remain poorly understood. The proposed work will apply bioinformatic methods to a well-characterized biorepository of carriers to advance the current understanding of progression from C. difficile carriage to disease, with the ultimate goal of informing future prevention efforts.